Modulation of gait dynamics post-stroke

PROJECT SUMMARY/ABSTRACT
My career goal is to improve the personalization of stroke gait rehabilitation and develop novel rehabilitation
technologies using neuromechanics-based data-driven modeling in conjunction with hypothesis-driven
experimental design. The proposed research aims to understand how neural constraints impact stroke survivors’
ability to coordinate execution-level joint dynamics to flexibly modulate whole-body center-of-mass (COM)
dynamics between slow inverted pendulum and fast spring-mass dynamics during walking; a task critical to
achieving stable, efficient, and rapid movement. My preliminary data in a single individual suggest that COM
dynamics are asymmetric post-stroke, but further characterization of joint coordination and COM dynamics is
needed to understand their relationship with interindividual and inter-limb differences in post-stroke walking
function and treatment responses. Two major methodological barriers to characterizing these relationships are
a lack of 1) metrics and techniques to encode complex, individual-specific gait dynamics post-stroke, and 2) long
time-series datasets containing diverse movement patterns needed to test neuromechanical hypotheses about
gait. To address these challenges, I will work with Sponsor Ting and Co-Sponsor Berman to extend data-
driven techniques developed in my doctoral research to identify COM dynamics and characterize their
relationships to joint dynamics; with Sponsor Ting and Co-Sponsor Kesar I will design and collect new datasets
from stroke survivors of diverse movement patterns using biofeedback during walking. Aim 1: Test whether
interindividual and inter-limb differences in COM dynamics post-stroke are associated with walking speed. I will
evaluate the similarity of baseline post-stroke COM dynamics to able-bodied (AB) adults and between paretic
and non-paretic limbs. Further, I will examine whether the paretic-limb transitions from inverted pendulum to
spring-mass dynamics at faster treadmill speeds, decreasing asymmetry in COM dynamics. Aim 2: Characterize
reductions in stroke survivors’ ability to modulate joint dynamics to achieve desired COM dynamics. Using visual
biofeedback to prescribe COM dynamics, I will test whether stroke survivors have reduced ability to emulate
COM dynamics compared to AB adults and determine if joint dynamics characterize COM dynamics less
accurately in stroke survivors than AB adults. Aim 3: Test whether sub-groups of individuals with similar COM
and joint dynamics predict biofeedback responses more accurately than discrete metrics. I will test whether,
across a range of biofeedback-prescribed COM dynamics, baseline COM and joint dynamics can classify
changes in joint dynamics with biofeedback more accurately than discrete clinical or biomechanical variables. I
will also have training in clinical trials by participating in Sponsor Kesar’s ongoing gait rehabilitation study. The
proposed research and training will complement my doctoral skillset, preparing me to lead independent research
combining experimental design and computational techniques to discover neuromechanical mechanisms
underlying gait dysfunction and develop novel gait rehabilitation for individuals with neurological injuries.

Public health relevance
PROJECT NARRATIVE Personalizing stroke gait rehabilitation hinges on our understanding of how neural constrains limit an individual’s ability to coordinate many muscles and joints to achieve relatively few task level goals, such moving the whole-body stably, efficiently, and quickly. This project will characterize interindividual and inter-limb differences in whole-body dynamics and joint-level strategies for achieving desired whole body dynamics during treatment. Identifying characteristic relationships between joint and whole-body dynamics may explain diverse treatment responses and provide novel metrics to characterize stroke gait rehabilitation.